Intersectional Approaches to Population-Level Health Research: Role of HIV Risk and Mental Health in Alcohol Use Disparities among Diverse Sexual Minority Youth

PROJECT SUMMARY
Alcohol is the most commonly used and abused drug among youth in the US; prevalence of alcohol use is
disproportionately higher among sexual minority youth (SMY) than among their heterosexual peers, especially
among those at the intersections of multiple marginalized identities. Alcohol use and abuse are associated with
a multiplicity of short and long-term negative health outcomes, including HIV vulnerabilities, alcohol and other
substance use dependence, neurocognitive deficiencies, and psychological distress. Despite the fact that
alcohol use and abuse during adolescence has important consequences for downstream health outcomes and
adult patterns of substance use, the majority of research among sexual minorities to date has focused on
college-aged populations. This gap in research with SMY is critical to rectify, particularly for SMY who
experience multiple, intersecting forms of marginalization based on sex, race/ethnicity, and sexual orientation.
Building on our team’s prior work in this area, we propose to use pooled data from the Local Youth Risk
Behavior Survey (YRBS), a national biennial survey of high school students that assesses sexual identity and
behavior, as well as health behaviors including alcohol use, HIV vulnerability, and mental health. Our uniquely
large dataset, which currently contains data from 2005 to 2019 (253 jurisdiction-years) and 950,295 high
school youth, will expand to include 2021, 2023, and 2025 data, resulting in an estimated 1,668,078 youth.
This will allow us to apply an array of complex epidemiologic approaches to assess the impact of alcohol use
on the sexual, mental, and physical health of SMY living in the US, and the disparities that exist between
multiply marginalized SMY and their peers. This proposal is a natural extension of our prior work (R01
AA024409) that resulted in numerous publications in high-impact peer-reviewed journals (e.g., Pediatrics,
American Journal of Public Health) and a diverse array of interdisciplinary collaborations. The current proposal
will continue these successes, incorporating an intersectional lens as well as additional advanced methods of
inquiry, including use of multilevel modeling to determine jurisdictional and temporal associations with alcohol
use and disparities in HIV risk; latent class analysis to describe alcohol use classes and their association with
minority status; and the impact of regional, school, and structural level factors that influence alcohol use and its
role in increased HIV vulnerability among diverse SMY. These approaches will allow us to continue identifying
critical pathways for intervention to ensure equitable health outcomes and minimize the risks associated with
alcohol use and abuse among notably vulnerable populations of youth.

Public health relevance
PROJECT NARRATIVE We propose to utilize the Youth Risk Behavior Survey (YRBS) to assess alcohol use disparities between sexual minority youth (SMY) and heterosexual youth at the intersections of multiple marginalized identities including sex and race/ethnicity, and to determine how these associations impact HIV vulnerability. The team’s pooled dataset, which contains 950,295 youth from local versions of the YRBS, will be extended to include YRBS data collected between 2021 and 2025, providing the opportunity to conduct innovative, intersectional research on the associations between alcohol use, HIV vulnerabilities, and mental health on a national scale and adapt novel methodologies for this purpose. This project builds upon a highly successful prior R01 which facilitated critical health disparities research, interdisciplinary collaboration, and high-impact publication, by strengthening the available sample and leveraging additional modes of complex quantitative inquiry to support innovation in analysis and application of results.